Metabolic and neuromodulatory basis of altered activated and deactivated cortical areas in healthy human aging

Project Summary/Abstract
Human healthy aging is associated with declines in cognition, memory, and processing efficiency. Two
leading theories to explain altered function are the mitochondrial theory of aging, in which mitochondria lose
the ability to provide sufficient energy to support function and altered GABA/glutamate neuromodulation.
Recent developments in calibrated functional MRI (fMRI) have allowed direct imaging of alterations in neuronal
activity in aging. Surprisingly, measurements of task-induced changes in oxidative metabolism (ΔCMRO2) have
found increased neuronal activation despite lower baseline CMRO2 in aging.
We propose to address this paradox, by using a novel combination of calibrated fMRI, functional 1H-MRS
(fMRS), and 1H[13C]-MRS approach to directly test the roles of mitochondrial aging and neuromodulation in
healthy aging. Our general hypotheses are: (i) The paradoxical increased functional response in healthy
aging, observed primarily in sensory areas, is a compensation for lower baseline CMRO2, but it is not sufficient
to achieve the same energetic support for neuronal function as in young subjects (mitochondrial aging theory);
and (ii) The inverse relationship between GABA concentration and BOLD activation established in young
subjects is blunted in elderly (neuromodulation theory). We will test these hypotheses with three specific aims.
In Aim 1 we will use a novel gas-free calibrated fMRI method to measure ΔCMRO2 in response to visual
task in healthy young and aged subjects. In Aim 2 we will perform, in parallel with calibrated fMRI, fMRS
measurements of inhibitory GABA and excitatory glutamate. In Aim 3 we will use 1H[13C]-MRS to specifically
measure neuronal CMRO2 (via the TCA cycle) which we showed is selectively decreased in aging visual cortex.
In parallel with our testing of changes in activated brain regions like the visual cortex, we will also perform
the same measurements simultaneously in the posterior cingulate cortex (PCC), which is a major hub of the
default mode network (DMN) that has been shown to deactivate during tasks. Resting-state fMRI studies in
aging have shown that the DMN connectivity is altered, but there have been no studies looking at its task
response using quantitative fMRI or fMRS methods. Understanding the metabolic and neuromodulatory
differences across activated and deactivated areas are crucial for understanding the basis of the altered
functional response in healthy aging. The proposed work has high potential human health significance both
for understanding basic mechanisms behind the alterations in neuronal activity in aging and in validating a
novel multi-modal MRI/MRS biomarker for evaluating these mechanisms and potentially assessing the
response to mechanism targeted therapeutics. Although 1H[13C]-MRS is not yet broadly available, we will
evaluate whether neuronal CMRO2 at rest determined from calibrated fMRI provides similar results. Because
the calibrated fMRI method does not require gas inhalation, it is broadly applicable to patient populations.

Public health relevance
Project Narrative If loss of function during brain aging is to be physiologically delayed or reversed, the age-induced mechanisms must be understood. Our proposed study is the first that directly assesses the impact of two leading mechanisms (mitochondrial and neuromodulatory) on proper neuronal response to functional tasks in human brain, in both activated and deactivated regions. The information generated will be critical in developing new therapeutics.